RFA-DP-21-001 DP006624 VA Pregnancy Risk Assessment Monitoring System (PRAMS)

Component A: Virginia Pregnancy Risk Assessment Monitoring System (PRAMS) seeks
to implement the CDC PRAMS protocol in Virginia for 2021-2025. PRAMS utilizes a complex
sampling methodology to collect data from Virginia women who have recently delivered a live
birth infant. Information on health behaviors and experiences before, during and shortly after
pregnancy is collected. Virginia uses PRAMS data to identify emerging health issues, establish
health objectives, track progress on state and national objectives, and develop and evaluate
public health policies and programs related to maternal and child health. Virginia PRAMS
provides statewide and some health district level data. PRAMS is the sole data source for the
majority of these indicators and provides critical data for many of Virginia’s ongoing initiatives
and grants, including the Title V Maternal and Child Health Services Block Grant and the
Virginia Neonatal Perinatal Collaborative (VNPC). PRAMS also provides population-level data
to a host of Virginia programs, including those related to breastfeeding, home visiting, dental
health, tobacco, and injury and violence prevention. PRAMS provides data on Healthy People
2030 goals related to access to health services, injury and violence prevention, immunization,
maternal and child health, family planning, early and middle childhood, mental health and
mental disorders, tobacco use, and oral health.
There are multiple avenues through which PRAMS has the ability to impact population
health. At its most basic level, PRAMS is used in Virginia to document trends in adverse birth
outcomes, the first step to understanding population health. Through Virginia’s increased
sampling of a high-risk population, PRAMS can further identify sub-populations at high risk and
correlates of risk and develop strategies and programs in response.
Success in this present application will mark Virginia’s fifteenth year of PRAMS funding
and operations. As such, major project components (e.g., staffing, sampling and data analysis,
data collection procedures and protocols, IRB approval, steering committee, etc.) are fully
developed and presently implemented. Major project components are revised by the state
PRAMS team in coordination with the Steering Committee and CDC PRAMS as operational
needs dictate.

Public health relevance
Component A Project Narrative Specific Aims Virginia PRAMS (Pregnancy Risk Assessment Monitoring System) supports the activities of the Virginia Department of Health (VDH) to improve maternal and child health in the Commonwealth through: 1) Surveillance of selected maternal behaviors and experiences that occur prior to, during, and after pregnancy; 2) Providing a high quality data source for ongoing monitoring of risk factors for maternal and infant health; 3) Addressing emerging issues, including post-disaster or pandemic surveillance needs, through the use of survey supplements, and; 4) Provision of data collection results to be used for program planning and evaluation.